Cancer Research Training and Education Coordination

CANCER RESEARCH TRAINING AND EDUCATION COORDINATION (CRTEC): SUMMARY
Through experienced leadership and continuous strategic investment, Hollings Cancer Center (HCC) has
spearheaded cancer-focused educational and professional development activities across the Medical
University of South Carolina (MUSC) for more than three decades. Inherent to its core mission, HCC offers an
innovative portfolio of training activities and career enhancement programs to maximize cancer-focused career
success and advance a diverse cancer research workforce. Buoyed by significant accomplishments, HCC
leadership renewed ongoing programs and expanded its cancer research career enhancement activities during
the current project period. These accomplishments include multiple HCC-driven initiatives and awards, such as
a renewed postdoctoral T32 for Integrative Training in Oncogenic Signaling (T32CA193201), HCC-funded
Postdoctoral and Graduate Fellowship programs, the SC Cancer Health Equity Research Consortium
(R25CA193088) summer undergraduate education award, SC Cancer Disparities Research Center
(CA210962), which includes an education and training core, and HCC-funded Clinical Scholars Program. As a
result, peer-reviewed funding has increased by 41% since the last renewal. Training at HCC spans the
education spectrum, from high school trainees to early-stage investigators, including continuing education for
healthcare professionals in the community. Cancer research training is cohesively integrated with an annual
cancer research symposium celebrating excellence across training disciplines and stages. What characterizes
HCC’s educational and training enterprise is its significant record of accomplishment in providing SC’s only
comprehensive, cancer-focused research education and training opportunities, the intentional inclusion of
cancer disparities education in its programs, and strong partnerships among key minority-serving institutions.
In the next funding cycle, the Associate Director of Education and Training, Benjamin Toll, PhD (CC), with
guidance from an internal Education and Training Leadership Council, HCC Executive Council, and HCC’s
External Scientific Advisory Board, is crafting several new initiatives that will create programs for the center’s
education and training pipeline and novel trainings for healthcare professionals to enhance trainee tracking and
evaluation system, and augment mentoring programs. New directions involve synergistic approaches with Plan
to Enhance Divesrity and Community Outreach and Engagement to launch the Developing Leaders Program
and a retention committee entitled Faculty Engagement and Advancement Team to foster critical faculty
engagement and execute more targeted approaches for recruiting and supporting individuals that have been
historically underrepresented in biomedical and cancer research. These initiatives will help retain and develop
a pipeline for future HCC leaders, expand collaborative cancer-oriented education and training programs with
Historically Black College & University partners, and establish a broad array of new mentoring initiatives and
integration of CRTEC with the new Office of Programs to Enhance Diversity.